Novel role of β-arrestins in Tauopathy

The major defining pathological hallmarks of Alzheimer’s disease (AD) are the accumulation of
amyloid β (Aβ) and hyperphosphorylated tau. Multiple GPCRs (i.e, β2AR, GPR3, AT2R, CXCR2,
& NMDARs) have been shown to play integral roles in AD pathogenesis. However, it is unclear
as to how a diverse array of GPCRs all positively impinge on Aβ and tau pathogenesis as well as
neurodegeneration in AD. Given that GPCRs share a common mechanism of action via β-arrestin
scaffolding signaling complexes, the central hypothesis is that the actions of β-arrestins
downstream of GPCRs directly impact AD pathogenesis. β-arrestins exist in three distinct states
in cells; 1) free unbound, 2) GPCR-bound, and 3) microtubule-bound, each with different signaling
capability. Previous studies have shown that β-arrestins are upregulated in AD brains and that β-
arrestins promote Aβ pathogenesis. However, it is unknown whether and how β-arrestins
pathogenically impinge on tauopathy and neurodegeneration in AD. Preliminary data indicate that
β-arrestin oligomers promote tauopathy via 2 distinct mechanisms: 1) directly competing with tau
for binding to microtubules (MT), thereby deregulating MT dynamics; 2) inhibiting tau clearance
by deregulating the autophagy machinery.
By utilizing molecular, cell biological, biochemical, electrophysiological, behavioral, viral, and
histochemical tools, this proposal will 1) validate the role of β-arrestins in tauopathy in vivo, 2)
validate the role of β-arrestins in tau/microtubule dynamics, and 3) investigate the role of β-
arrestins in p62-mediated autophagy and tau turnover. This proposal will validate whether β-
arrestins and their oligomeric status serve as promising therapeutic targets to mitigate tau
pathogenesis.

Public health relevance
Tau pathology (tauopathy) is a prevailing hallmark of Alzheimer’s disease (AD) and multiple other neurodegenerative diseases. This proposal aims to understand how β-arrestins, proteins known to regulate various neuronal signaling receptors (GPCRs), contribute to tauopathy in brain. This proposal will allow us to determine whether β-arrestins and their conformational states serve as promising therapeutic targets to mitigate tau pathogenesis.